SIRT5 inhibitors and degraders as novel treatments for Ewing sarcoma

Abstract
Ewing sarcoma (EWS) is an aggressive tumor arising in soft tissue and bone of children and young
adults. EWS is treated with a combination of cytotoxic chemotherapy, local radiation, and/or surgery.
Patients with localized disease show a favorable overall survival rate. However, there is still a pressing
need for new therapeutic approaches for EWS. Patients with metastatic or recurrent EWS have a very
poor prognosis. Moreover, current EWS treatments are associated with many short- and long-term
sequelae, e.g. accelerated cardiovascular disease and secondary cancers. EWS-FLI1 is the fusion
oncoprotein present in most cases of EWS. It functions as a pioneer transcription factor to affect
expression of many target genes. The aberrant EWS transcriptome represents a potential therapeutic
target in EWS. This proposal focuses on the sirtuin SIRT5 as a novel therapeutic target in EWS. SIRT5
is found throughout the cell, and regulates protein targets in diverse pathways by removing negatively
charged modifications on lysine residues, including succinylation. Although normal cell types and whole
mice tolerate loss of SIRT5 with minimal phenotypes, we have found that specific cancers, notably
including EWS, are exquisitely dependent on SIRT5, and rapidly undergo apoptosis following SIRT5
depletion. We have linked this effect to a role for SIRT5 in desuccinylating nuclear histones, thereby
modulating gene expression in EWS. We and others have shown that SIRT5 is in principle amenable to
selective inhibition or degradation with small molecules. Our long-term goal is to evaluate SIRT5 as a
potential therapeutic target for EWS. The objective of this proposal is to generate new biological insights
into SIRT5 function in EWS, and characterize SIRT5 inhibitors and SIRT5 PROTAC-based degraders.
The central hypotheses of this application are that: 1) SIRT5 is required for EWS cell survival via histone
desuccinylation and regulation of gene expression; and 2) SIRT5 inhibitors and degraders will represent
useful tool compounds to interrogate SIRT5 biology, and a starting point for potential future EWS
therapeutics. The rationale for this application is that EWS cells show exquisite vulnerability to SIRT5
loss-of-function, while other cell types and whole mice show no major ill effects. Hence, SIRT5 inhibition
would likely be well tolerated clinically. The work will take place in the context of two Specific Aims. First,
we will elucidate the impact of SIRT5 and Ksucc on histones and gene expression, using mass
spectrometry along with transcriptomic and epigenomic approaches. Second, we will optimize and
validate SIRT5 inhibitors and degraders, using medicinal chemistry approaches and based in part on
SIRT5-inhibitor co-crystal structures. The application is innovative, in that no published data currently
link SIRT5 to EWS, and no potent and selective SIRT5 inhibitors or PROTACs have as yet been
described. The work is significant, since there is an unmet clinical need for improved therapies for EWS.

Public health relevance
Narrative The proposed studies are relevant to public health, because discovery of novel means to treat Ewing sarcoma, exerting fewer deleterious sequelae in survivors, represents a significant unmet need in pediatric oncology. This work is thus relevant to NIH’s mission, in the context of supporting research to identify cures for human disease.